Genomic Editing & Screening

ABSTRACT
The major goals of the Genomic Editing and Screening (GES) Core Facility are 1) to provide CRISPR-Cas9
sgRNA gene knockout and knock-in services targeting mutations/genes-of-interest towards the creation of
stable cell lines, including adoption of base editing and prime editing techniques to enhance CRISPR knock-in
efficiency for targeted edits and a lower risk of spurious indels; 2) to offer customized focused and full-genome
knockout / knockdown technologies via pooled CRISPR-Cas9 and arrayed siRNA libraries, respectively; 3)
to provide cutting-edge RNA interference (RNAi) gene target knockdown technologies to facilitate the
discovery of novel cancer targets and complex, aberrant intracellular pathways, utilizing Pol II-driven,
enhanced Mir-E-based shRNA for high-efficiency protein knockdown with single-copy integration using
a panel of lentiviral plasmid backbones for delivery; 4) to provide small barcoding libraries (5-20K
guides), such as CellTag (V1,V2, & V3), and large barcoding libraries (245K guides and greater), such
as LARRY and Watermelon, for lineage tracing and subsequent delineation of lineage-associated
behavior; 5) to provide the CRISPR-mediated transcriptional activation/interference
(CRISPRa/CRISPRi) technologies to allow scientists to investigate induced/suppressed gene
expression within native cellular context, therefore facilitating powerful applications in large-scale of gain-offunction/
loss-of-function genomic screens and the engineering of cell-based models; 6) to produce highly
efficient lentiviruses in two formats (standard and concentrated) for transducing patient-derived xenograft
(PDX) and cell lines. 7) to validate the efficiency of CRISPR and RNAi using western blotting
(WB), real-time PCR (qPCR), and Immunofluorescence (IF) technologies; 8) to assist
researchers in employing the Core’s high content phenotypic screening (HCS) platforms using fixed cells,
including the Yokogawa CellVoyager CV8000 Nipkow spinning disk confocal HCS System, equipped with
machine-learning functionalities as well as two GE Incell 6000 laser line scanning confocal imagers,
equipped with a robotic arm plate-loader for screen automation; 9) to enable live cell imaging and kinetic
experiments with the two Sartorius-Essen IncuCyte S3 systems, with modules for organoid tracking,
cell-by-cell analysis, and advanced classification of live-cell phenotypes; 10) to support researchers
with liquid handling workstation-based small molecule compound screening, allowing investigators to
employ high throughput screening (HTS) chemical biology approaches with our collection of ~123,000
compounds. Promising compounds can then be matriculated into the Early Therapeutic Center
(ETC) and Tri-Institutional therapeutic Drug Initiative (TRI-I TDI). Further, in the coming year the GES
Core seeks to identify on-site research partners to launch a new initiative in Functional Precision
Medicine (FPM), utilizing our HTS expertise and extensive chemical library collection to provide fPM services
for clinicians and patients at MSKCC.
Overall, this comprehensive Core Facility dedicated to functional genomics and screening enables mechanismbased
science through target identification and phenotypic imaging, offering custom reagents, screening
of small molecule compound collections, and cell line generation services to a large number of the
MSK Center’s members.